Role of functional iron deficiency in alcohol-associated liver disease

PROJECT SUMMARY
Alcohol-associated liver disease (ALD) accounts for approximately 45% of liver disease related deaths in the
United States. However, there are no treatments for this significant health problem. A better understanding of
the mechanisms underlying the progression from alcohol associated steatosis to hepatitis and cirrhosis would
potentially lead to the development of novel therapeutic strategies for ALD treatment. Mitochondria plays an
important role in supporting the oxidative metabolism of alcohol and acetaldehyde by expressing aldehyde
dehydrogenase 2 (ALDH2) and regenerating NAD+, an essential cofactor for ALDH2 as well as alcohol
dehydrogenase (ADH). Mitochondrial dysfunction is a hallmark change in chronic alcohol abuse and mediates
exacerbated liver injury advancing the progression of ALD. However, the molecular foundation underlying ALD-
associated mitochondrial abnormality remain to be elucidated. Iron is critical for mitochondrial respiration
dependent on the biogenesis of iron-sulfur cluster (ISC) that mediates electron transfer in mitochondrial complex
I-III. Our preliminary study identified that divalent metal transporter 1 (DMT1), an iron transporter that mediates
endosomal iron exit and mitochondrial uptake, and frataxin (FXN), an essential mitochondrial iron chaperone
that mediates ISC biogenesis, were markedly decreased in the liver of human patients with acute-on-chronic
alcoholic hepatitis. This finding suggests that chronic alcohol consumption induces functional iron deficiency in
the hepatocytes due to defective ISC biogenesis. Moreover, mice with hepatocyte-specific knockout of DMT1
displayed significantly increased liver injury and impaired alcohol metabolism. We thus hypothesize that chronic
alcohol abuse induces hepatic FID-dependent mitochondrial dysfunction and impairment of alcohol metabolism
promoting the progression of ALD. In Aim 1, we will identify the signature changes of hepatocellular iron
metabolism in acute versus chronic alcohol drinking by utilizing chronic-plus-acute binge drinking mouse model
and human liver samples and the cutting-edge multiplex microscopic analysis. Aim 2 will prove the detrimental
role of functional iron deficiency as well as hepatic absolute iron deficiency in the pathogenesis of ALD by utilizing
multiple hepatocyte-specific knockout mouse models. Aim 3 will attempt to unveil that endoplasmic reticulum
stress of the hepatocytes induces DMT1/FXN downregulation impairing mitochondrial iron acquisition and ISC
biogenesis in ALD. This exploratory study will demonstrate a paradigm-shifting concept that functional iron (ISC)
deficit exerts strong adverse effects on alcohol-induced liver injury, shedding novel light on the development of
new therapeutic modalities against ALD.

Public health relevance
Project Narrative Mitochondrial metabolic activity facilitates the oxidative metabolism of alcohol and its highly toxic intermediate product acetaldehyde. Our study for the first time suggested that human patients with alcoholic steatohepatitis develop functional iron deficiency (FID) that impairs mitochondrial function in the hepatocytes. The objective of this proposal is to unravel the impact of hepatic FID on alcohol-induced liver injury and the mechanisms leading to FID in chronic alcohol drinking.